Alzheimer's disease-specific extracellular vesicles: from pathology to novel biomarker discovery

ABSTRACT
Alzheimer’s disease (AD) is one of the most devastating neurological diseases characterized by
progressive cognitive impairments, including memory loss. The mechanisms of disease
progression are not yet fully elucidated, and to date there are no reliable biomarkers for early
detection of pathogenic components. Improved capabilities to assess central nervous system
brain health with peripheral biofluid samples (Liquid Biopsy) will expand clinical options at all
stages of disease.
Extracellular vesicles (EVs) of brain origin (bdEVs) cross biological barriers and can be traced
back to specific parent cell types suggesting novel diagnostic, prognostic, and monitoring tools,
revolutionizing identification and care of AD as well as understanding pathogenesis. bdEVs
carry cargos involved in neurotransmission or neuroprotection and facilitate communication
between brain cells also making them “targetable agents” of pathology.
To lay the groundwork for more efficient peripheral bdEV studies, we have compared the protein
content of brain homogenates with purified EV fractions of control and late-stage AD brains.
Proteome differences were most pronounced in EVs, while certain cells release more EVs or
EVs with higher density of cell-specific surface markers. Based on these novel findings, we
propose to use human induced pluripotent stem cell (hiPSC) models of neurons, astrocytes and
microglia to test the specificity and sensitivity of the top CNS surface markers we identified in
our preliminary studies as enriched on bdEVs from different cell types and as more abundant in
AD patients versus controls (Aim 1). To investigate aging- and neurodegeneration-related
proteins and RNAs that were differentially regulated in AD bdEVs, we will study three different
sources of EVs, including iPSC-derived progeny (Aim 1), brain tissue (Aim 2), and plasma (Aim
3). We will use the same sources to discover new molecular signatures for disease detection
and monitoring.

Public health relevance
PROJECT NARRATIVE The mechanisms leading to the spread of Alzheimer’s disease (AD) in the brain are not understood. We will study how AD-specific brain derived Extracellular Vesicles (bdEVs) affect the progression of AD, and their potential as blood-derived biomarkers. We will study in tissue from well characterized patients and controls of the Johns Hopkins Alzheimer’s Disease Research Center (ADRC): brain tissue, stem cell models of neurons, astrocytes,microglia and plasma.